Quantitative Systems Biomedicine and Pharmacology for Multiscale Tissue Damage

PROJECT SUMMARY/ABSTRACT
Chemical, physical, and biological processes interact across multiple length and time scales, leading to
consequences for human physiology, disease progression, and medical therapeutics. The collective behaviors
of these processes across multiple scales cannot be explained by studying the isolated parts at a single scale.
Multiscale systems biomedicine approaches allow for quantitative descriptions of interconnected processes,
which aid in understanding the mechanisms for the links between the processes that cannot be decoupled easily
in experiments. The overall vision for the PI’s research program is to develop multiscale computational models
and methods for building and solving those models to enhance understanding of the mechanisms governing
tissue remodeling and damage as a result of diseases and infections and to simulate the treatment of those
conditions to improve human health. The proposed research addresses the unmet need to compile the multiple
processes that contribute to homeostatic tissue remodeling and the onset and progression of chronic tissue
damage into systematic computational frameworks capable of taking the interconnected chemical, physical, and
biological factors into account in a coupled fashion and in the appropriate magnitudes and sequences to make
testable predictions. In the absence of such frameworks, unraveling the network of events in tissue remodeling
and damage will continue to be perplexing, and the development of effective pharmaceutical treatments will likely
remain piecemeal and slow. The proposed research focuses on tissue damage processes that involve changes
to the extracellular matrix (ECM), which provides biochemical and structural support to surrounding cells.
Building multiscale computational models for the chemical and biological processes that result in structural
addition or depletion of ECM, which damages various tissues, and related immune involvement will increase
fundamental mechanistic understanding of human tissues and lay the foundation for advances in disease
treatment and prevention. The rationale is that multiscale computational models provide insights into the complex
network of the effects of molecular-level actions of chemicals such as glucose, cytokines, hormones, and
pharmaceuticals on the cellular, tissue, and whole-body levels of physiology. The goal for the next five years is
to create and refine multiscale models to improve physiological understanding of tissue remodeling and damage
in various human, animal, and engineered tissue microenvironments. Two key challenges related to the unmet
need will be pursued: 1) relating molecular and cellular level information to macroscopic tissue and organ
systems level clinically relevant phenotypes and 2) cell migration through 3D microenvironments. The goal and
key challenge areas build upon the systems biomedicine methods the PI’s lab has adopted and the recent results
they have produced related to multiscale computational models applied to diabetic kidney disease, lung infection
and fibrosis, cancer and immune cell migration, bone remodeling, and polymer implants for drug delivery.

Public health relevance
PROJECT NARRATIVE Through environmental, metabolic, hormonal, and immunological stimuli from localized or systemic sources, diseases and pathogens can interferewith the complex balance between the growth and break up of tissues that occurs in normal healthy conditions. This project seeks to use computational modeling techniques to connect the chemical and biological processes that damage various tissues. This work will increase understanding of human tissues and lay the foundation for advances in disease treatment and prevention.